Structure-function relationship of the insulin receptor on cell proliferation and metabolism

PROJECT SUMMARY
Dysfunction in insulin receptor (IR) signaling is implicated in various metabolic disorders, including diabetes and
cancer. Since the discovery of insulin more than a century ago, considerable effort has been made to elucidate
its metabolic function. Given the high incidence of patients with both diabetes and cancer and the links between
tumorigenesis and hyperinsulinemia (or elevated insulin level in the blood), there is a pressing need to reassess
insulin’s “mitotic” function via activation of the MAPK signaling pathway.
The primary objective of my research is to understand the molecular mechanism and biological function
of biased agonism of IR activation by designer ligands. Additionally, I aim to use these designer ligands as tools
to elucidate the regulatory mechanism of IR trafficking system. Recently, we functionally characterized and
determined the cryo-EM structures of insulin-bound and designer ligand-bound IR. Notably, we observed that
designer ligand induces a distinct active conformation of IR compared to insulin and exhibits biased agonism
against the MAPK signaling pathway through the same IR. Furthermore, my preliminary data demonstrates that
the designer ligand reduces IR levels in vivo and in cultured cells by promoting the degradation of internalized
IR, rather than recycling it back to the cell surface. These results raise immediate questions: (i) how do different
IR active conformations induce biased agonism and modulate downstream signaling pathways, (ii) what are the
biological outcomes of the biased agonism against the MAPK signaling pathway, and (iii) which regulators sort
IR for recycling or degradation?
To address these questions, in Aim 1, I will elucidate the mechanism and biological function of biased
agonism of designer ligands in cultured cells and mice. In Aim2, I will use designer ligands as tools to identify
regulators of IR trafficking by proximity-dependent biotinylation proteomics.
By combining cell biology, biochemistry, proteomics, and mouse physiology, I aim to establish structure-
to-function relationship between IR, its downstream signaling pathways, and physiological processes. This
research project will be conducted at Columbia University under the co-mentorship from Dr. Eunhee Choi and
Dr. Domenico Accili. The collaborative environment at Columbia, coupled with distinct yet complimenting
expertise of my sponsors in structural biology, cell signaling, and physiology, provides me with unparalleled
access to a wealth of resources, both intellectual and technical. These resources are crucial for the successful
execution and accomplishment of my proposed multidisciplinary research project and training.

Public health relevance
PROJECT NARRATIVE Links between hyperinsulinemia and tumorigenesis mandate reassessment of the “mitotic” function of insulin, and the contribution of insulin receptor (IR) downregulation to insulin resistance in patients with type 2 diabetes calls for research to elucidate the regulatory mechanism of IR trafficking system. Using designer insulin mimetic peptides, I aim to understand the molecular mechanism and biological function of biased agonism and IR trafficking on proliferation and metabolism through proteomics and functional assays. My research will provide crucial insight into how insulin promotes cell proliferation and how regulators of IR trafficking modulate IR levels on the cell surface.